Role of heat shock transcription factors (HSFs) in hematological malignancies

Abstract
Among the human hematological malignancies, acute leukemia types including acute myeloid leukemia
(AML) accounts for 4% of all cancer deaths worldwide and 6% of cancer in the US population. AML is the
second most common type of diagnosed leukemia in pediatric and adult populations but most frequently
occurs in adults accounting for about 30% of all leukemia cases. Inductive therapy generally involves
intensive and genotoxic chemotherapy that can lead to high remission rates (>80%), but the long-term
survival rates for AML subtypes are only 30-50%. Indeed, the prognosis of primary resistant and relapsed
leukemia in pediatric and elderly populations remains very poor. Currently, there is a strong rationale for
immune intervention in cancers, including hematological malignancies, but recent clinical trials have
demonstrated that the benefits of immunotherapy are relegated to a small fraction (~20%) of cancer patients,
including those with AML. This prompts the need for greater understanding of the mechanisms underlying
leukemic cell plasticity and adaptation, as well as developing novel therapeutic approaches to achieve more
effective and selective cure rates for primary drug-resistant and relapsed leukemia.
Hsf1, as the master activator of the classical heat shock response and guardian of the proteome, has been
implicated in the pathogenesis of cancer. Our preclinical studies have revealed the existence of a
coordinated, Hsf1-dependent protein homeostatic and metabolic program that, when inactivated, can lead to
cancer regression and, in particular, effective leukemia inhibition. Encouragingly, our recent studies unveiled
a highly novel and clinically significant role for Hsf1 inhibition in metabolic reprogramming and enhancement
of anti-tumor T cell immunity. This may provide a new approach to improve leukemia treatment by improving
the anti-tumor immune capacity targeting Hsf1 activity. We propose that by inhibiting supportive non-
oncogene addiction pathways, interfering with tumor-promoting metabolic reprogramming, and improving the
predicted power of anti-tumor immunity through targeting of Hsf1 activity, we can develop a valid strategy for
therapeutic interventions in leukemia. Our experimental strategy entails the following two major approaches:
1. Determine the impact of Hsf1 deletion on AML induction and explore its therapeutic potential for advanced
chemotherapy-resistant AML, and 2. Investigate the therapeutic impact of Hsf1 deletion on improved MHC-
restricted TCR or chimeric antigen receptor (CAR)-T cell-based immunotherapy for primary and drug
resistant/relapsed human AMLs. In summary, the long-term translational goal of the project is to test the
potential of Hsf1 targeting in human AML. It will also provide proof-of-concept for targeting Hsf1-mediated
metabolic programs for immunotherapeutic application of chemotherapy-resistant hematological
malignancies.

Public health relevance
Narrative Therapeutic exploitation of oncogene addiction has become a central aim of modern cancer therapy, but effective targeted therapies for chemotherapy resistant and/or relapsed hematopoietic malignancies including acute myeloid leukemia (AML) are lacking. In this proposal, a collaborating team of experts will investigate whether a valid approach for therapeutic interventions in AML can be based on a strategy to inhibit supportive non-oncogene addiction pathways, interfering with tumor-promoting metabolic reprogramming and improving the predicted power of anti-tumor immunity through depletion of Hsf1. This effort may provide an advancement to overcome key existing barriers in refractory AML management.